Pilot Projects Program

ABSTRACT
PILOT PROJECT PROGRAM. The overarching mission of the University of Louisville Diabetes and Obesity
Center is to enhance and enrich research into the mechanisms underlying cardiometabolic health and disease.
In line with this mission, the Pilot Project Program of Phase III of the COBRE will provide financial, technical, and
intellectual support to pilot projects in the areas of diabetes, obesity, and cardiovascular biology. Applicants for
the Program will derive primarily from junior faculty within academic departments at the University of Louisville
who have an interest in developing research programs in cardiometabolic disease. Additionally, meritorious
projects submitted by mid-career and senior investigators proposing to change fields or direct their future
research toward cardiovascular or metabolic disease will be considered for funding. Pilot project grant
applications will be solicited annually and awarded for a period of not more than two years based on the review
and recommendations of internal grant evaluators and the External Advisory Committee. In addition, we will
provide each awardee with a strong mentorship team to chaperone the development of their projects to the level
required for federal funding and to provide career guidance. The specific objectives of the program are to: (1)
support innovative cardiometabolic research; (2) provide scientific and professional mentorship to award
recipients; (3) strengthen the competitiveness of the Diabetes and Obesity Center; and (4) monitor efficiency
and effectiveness of the pilot program. We will encourage projects that have a high probability of both integrating
with and advancing the knowledge and capabilities of the current Center. This approach will help ensure that
we increase the mass of investigators in the Center as well as augment our ability to conduct basic and
translational research.